Molecular Complete Response in Blood as a Predictor for a Pathologic Complete Response after Neoadjuvant Therapy fo Breast Cancer

Project Summary/Abstract
The ability to treat breast cancer using patient specific regimens is not yet feasible. For example, oncologists
use prior clinical trials data to recommend multiple therapies based upon features of the tumor and clinical
stage of the patient. However, these data are averaged from large groups of patients that are then applied to
each individual. Therefore, oncologists end up treating the majority of patients with multiple therapies knowing
from past clinical trials that most patients do not need these additional therapies, resulting in overtreatment.
For early stage breast cancer, this is because there is no reliable method to identify patients that truly have
microscopic residual disease after primary therapy versus those that are already cured. The proposed project
addresses this conundrum. The research team will employ the newer technologies of digital PCR (dPCR) and
next generation sequencing (NGS), to reliably detect and quantify plasma tumor DNA (ptDNA) molecules shed
into the circulation from cancer cells. They have already demonstrated the ability to detect microscopic residual
disease using these technologies in early stage breast cancer patients. The team proposes an ambitious
project to address unmet needs in early stage (curative intent) breast cancer, to ultimately determine who truly
needs additional therapy vs. those patients that are already cured. They propose to evaluate Stage II/III breast
cancer patients undergoing neoadjuvant therapy (NAT) and define whether absence of ptDNA after NAT can
predict for complete elimination of tumor cells at the time of surgery, termed a pathologic complete response
(pCR). Three specific aims are proposed. Aim 1) Identification of somatic mutations in early stage breast
cancer using NGS. The team will test the feasibility of using plasma DNA to identifying tumor specific
mutations in Stage II/III breast cancer patients prior to any therapy. The success of this aim will preclude the
need for obtaining diagnostic tissue samples for NGS, which are often exhausted or unobtainable. Aim 2)
Detection of somatic mutations in plasma using dPCR. The successful detection of mutations in preNAT blood
by dPCR will validate mutation markers for serial testing of blood samples for each individual patient. Aim 3)
Predictive value of ptDNA for residual disease and pathologic complete response (pCR). Using dPCR, the
team will determine whether absence of ptDNA in blood after NAT but prior to surgery predicts for pCR. The
success of this study will set the stage for future trials to determine if patients without detectable ptDNA after
NAT can safely forego surgery, similar to the paradigm shift in using sentinel lymph node biopsies to avoid
axillary dissection. Additionally, the presence of ptDNA after NAT and surgery may identify a subset of patients
with significant risk for future recurrence, which could serve as a platform for future clinical trials. Ultimately
measuring ptDNA will enable individual therapy options and change the current practice of overtreatment in
early stage disease.

Public health relevance
Relevance The proposed study is relevant to public health because it addresses an ongoing unmet need in clinical oncology: overtreatment. Currently there are no technologies to accurately identify which patients truly need additional therapies and which are already cured with surgery or systemic therapies. The proposed research will determine if plasma tumor DNA can reliably identify patients with residual cancer thus changing the practice and paradigm of breast cancer therapy, from “one size fits all” to individualized treatment planning.